Automated Quantitative Ulcer Analysis (AQUA): Diagnosing Organism Types

PROJECT SUMMARY/ABSTRACT
Microbial keratitis (MK) is an emergent, painful infection of the cornea and a leading cause of
worldwide blindness. A key modifiable driver of vision loss in MK is the lack of a reliable, rapid,
and effective strategy to identify the causative organism at disease presentation. Point-of-care
tests are not available, are experimental, and are cost-prohibitive. The lack of point-of-care
organism identification leads clinicians to be unsure about treatments, affecting patient
outcomes. There is a critical need for developing practical, widely available strategies to rapidly
identify the causative organism type and to effectively convey the results to eye clinicians. The
long-term goal is to create adaptable low-cost strategies that support rapid, equitable MK clinical
decision-making. This proposal’s objective is to create: (1) knowledge about MK organism
identification, (2) an Automated Quantitative Ulcer Analysis (AQUA) algorithm to classify
organism types, and (3) a point-of-care AQUA decision tool to aid clinicians. Our central
hypothesis is that a simple platform integrating the AQUA algorithm and decision tool will meet
algorithm performance standards and will improve decision making at patient presentation. This
hypothesis is supported by preliminary data that has established the AQUA algorithm
performance, the targeted performance required to achieve a net benefit for clinicians, and the
identification of the domains for an MK decision tool. We will achieve the following Specific
Aims: (1) identify relative weights for risk factors associated with organism types, (2) create and
validate a novel machine-learning algorithm that identifies MK organism types, (3) establish the
drivers of decisions at point-of-care, and (4) build and assess a decision tool that support
clinicians. The project will create fundamental knowledge on MK and on decision making for
MK, develop and freely-distribute novel machine learning algorithms from a diverse population
and develop MK decision tools. This work will create a low cost point-of-care strategy for
clinicians who are managing a complex, rapidly-moving, and visually-impactful disease. It will
also create open-source algorithms, data, and models for researchers to apply broadly.

Public health relevance
NARRATIVE Microbial keratitis, a leading cause of worldwide visual impariment, disproportionally affects people with lower socioeconomic status. The National Eye Institute’s strategic plan highlights the critical need for point-of-care strategies to diagnose microbial keratitis. The proposed research will create open-source novel machine-learning algorithms to identify causative organisms of microbial keratitis at the point-of-care, using low-cost images and data from geographically-diverse cases, and integrate this information into a decision tool to inform treatment decisions for patients.